Data Management & Analysis Core: IDEAL shapes vaccine response, susceptibility to respiratory infectious disease and asthma

PROJECT SUMMARY: IDEAL Data Management Core (DMC)
The overarching goal of the proposed immune development in early life (IDEAL) project is to employ systems
biology to characterize childhood immune trajectories in order to define endotypes of key clinical outcomes such
as vaccine responsiveness, respiratory infection and asthma. In support of this effort, the Data Management
Core (DMC) will establish and maintain a cloud-based discovery environment, consisting of data storage and
computational tools to perform integrative systems analyses of clinical data, lab sample management, and high
dimensional assay results. The DMC will facilitate collaborations between the IDEAL Projects and Cores
including data sharing, submission to public repositories, and engagement with the external research community.
The broad goals of the DMC are reliable data capture and retention, ongoing quality assurance (QA), and
access/computational resources for integrative analyses. We articulate these goals through three Specific Aims,
including establishment of digital infrastructure for data capture, management, and analysis; rigorous quality
control (QC) and QA; and biostatistical and bioinformatics expertise for analysis.
Our data management architecture is designed on the basis of improved institutional capabilities for reliable
cloud-based clinical data management, experimental assay QC/QA, and analytic support. We have worked
closely with the BCH Research Computing Department to implement a system for IDEAL collaborators that will
combine security and reliability with accessibility and state-of-the-art computational tools and resources. Our
approach offers many advantages over more traditional server-based architecture, not the least of which is a
fruitful collaborative computing environment for integrative analyses and scientific discovery.
Any scientific endeavor of this scope and scale requires robust data management plans, infrastructure, and
operations. Indeed, there can be no practical integration of data without an environment to link these data across
platforms. The DMC’s integrative function is necessary to leverage the distinct strengths of the IDEAL projects
and cores into scientific synergies. We expect our integrated discovery environment will augment the scientific
value and productivity of the overall IDEAL study. The DMC will enable us to discover endotype-specific
molecules and pathways, that may serve as prognostic and/or actionable biomarkers to predict clinical outcomes
and/or that represent targets for interventions that redirect IDEAL towards health.